Sexual Orientation and Gender Identity (SOGI) Data Collection Program Implementation and Evaluation

Project Summary/Abstract
Not applicable for supplement application

Public health relevance
Narrative Not applicable for supplement application